Using geospatial science to maximize the opportunity to access ART in Africa

PROJECT SUMMARY / ABSTRACT
This proposal is to develop and implement methods for quantifying geographic disparities, within Sub-Saharan
African countries, in the opportunity for people living with HIV (PLHIV) to access antiretroviral therapy (ART);
and to identify optimal strategies for reducing such disparities. The methods that we will develop constitute a
novel analytic framework, which we will use to complete our three Specific Aims: (1) First, we will develop a
spatial interaction model which can be applied in any SSA country to estimate the geographic opportunity to
access ART and to identify disparities in this opportunity. We will apply the model to Malawi, which has one of
the most severe HIV epidemics in the world, and where our previous studies have shown that PLHIV face
substantial geographic disparities in accessing HIV care. To do so we will analyze a series of datasets, including
the nationwide Malawi Population-based HIV Impact Assessments [MPHIAs]; the MPHIAs were collected in
2015/16 and 2020/21, spanning a period when ART coverage increased substantially. (2) Second, we will
quantify the geographic relationship between the opportunity to access ART and its actual utilization, and
determine the degree to which this relationship changed between the two timepoints. (3) Third, we will use our
modeling framework in further analyses of the MPHIA 2020/21 dataset with the objective of identifying optimal
strategies to reduce geographic disparities in the opportunity to access ART; both through the location of new
healthcare facilities (HCFs) and through the allocation of additional supplies of ART. We will conduct these
studies through a U.S.-Malawi collaborative team.

Public health relevance
PROJECT NARRATIVE This project will develop a new type of mathematical model, which could be used in any country in Sub-Saharan Africa to identify geographic disparities in the opportunity for people living with HIV (PLHIV) to access antiretroviral treatment (ART), and then to determine optimal strategies for reducing these disparities. We will demonstrate the utility of the model by analyzing a series of datasets from Malawi, a low-income country with one of the most severe HIV epidemics in the world. In doing so we will help advance UNAIDS’ 2021-2026 global strategy, which emphasizes the application of novel, data-driven approaches for achieving a more equitable access to HIV interventions.